Core A: Administrative

Core A (Administrative Core) Summary
The Administrative Core A (hereafter, Core A) will serve as the central entity to direct, oversee,
and ensure the mission of the Flavivirus and Alphavirus ReVAMPP (FLARE) Center. The goal
of Core A is to provide administrative support, financial and regulatory compliance, operational
logistics, and scientific input and oversight of the research activities performed by the five
Projects, the Data Management Core and the three Scientific Cores. Core A also will function
to strengthen communication and data sharing within the FLARE Center, within the larger
ReVAMPP network, and with other external stakeholders to ensure successful execution of the
proposed aims in a highly collaborative environment. The following services, structured into two
aims, will be provided by the Administrative Core A: (Aim 1) To provide overall grant
management for the FLARE Center, such as budgetary support and fiscal oversight for the
overall center; the nomination and establishment of a Scientific Advisory Board (SAB) and
coordination of their activities; in collaboration with Project and Core Leaders, assurance of
regulatory compliance as well as NIH required documentation; the development and
implementation of measures to evaluate research progress of each Project and Scientific Core,
as well as a conflict resolution plan. Moreover, Core A will support the publication of FLARE
Center -derived manuscripts and administratively and financially support travel to the annual
ReVAMPP Network-wide review meetings and mandatory ReVAMPP Center progress meetings.
(Aim 2) To facilitate communication and collaboration within the FLARE Center as well as with
external stakeholders to ensure a highly collaborative environment with timely information
exchange. Specifically, Core A will promote regular communication and collaborations between
Projects and Cores, including industry partners, as well as with the ReVAMPP Coordinating and
Data Sharing Center (CDSC). Furthermore, Core A is committed to preparing the next generation
of researchers for pandemic preparedness and, particularly, by supporting the mentoring and
career advancement of trainees and faculty who are women or members of historically
underrepresented or marginalized groups in science. In addition, Core A will maintain
communication with the NIAID program officer(s) and other NIAID staff, coordinate reports to the
NIH, and ensure compliance with NIH and local institutional requirements, as well as facilitate
communication and support collaborative research activities with other ReVAMPP centers and
outside collaborators.